Implications of Changes in Islet Exosomal Cargo in Type 1 Diabetes

PROJECT SUMMARY
Extracellular vesicles (EVs) are membrane bound nanoparticles that can interact with other cells
as a means of cell:cell communication. Emerging data suggest that β cell-derived exosomes, an
EV subtype released by exocytosis of multivesicular bodies, may act as paracrine effectors in
islet health. Given the potential for exosomes to play a role in β cell communication with
surrounding cells in the islet microenvironment, a critical need exists for deliberate research
defining mechanisms of β cell exosome biology under physiologic and pathophysiologic
circumstances. β cell expression of the transmembrane immune checkpoint protein death-ligand
1 (PD-L1) plays a key role to support β cell survival in type 1 diabetes (T1D). Preliminary data
suggest that β cell exosome membranes carry PD-L1, and that exosomal PD-L1 is upregulated
by cytokine treatment of parent β cells. Our central hypothesis is that stressed β cells in the T1D
microenvironment alter their exosomal contents to include protective mechanisms aimed at
evading β cell destruction associated with autoimmunity. Aim 1 will elucidate the mechanistic
etiology of altered β cell exosome PD-L1 cargo. We hypothesize that proinflammatory interferon
signaling activates molecular regulators of intracellular β cell PD-L1 that, in concert with
mediators of exosome biogenesis, increase total exosomal PD-L1. Chemical and genetic
manipulation will be used to test impacts of these pathways on β cell exosomal PD-L1. Aim 2
will test the hypothesis that via transfer to or interaction with surrounding β cells and T cells, β
cell exosomal PD-L1 loading is a protective mechanism shielding β cells from autoimmune
destruction. Use of β cells differentiated from a human induced pluripotent stem cell line
overexpressing GFP-tagged PD-L1 will allow for direct tracking of PD-L1 transfer and binding to
other β cells and CD8+ T cells. Aim 3 will employ a novel microfluidic device to test the
hypothesis that PD-L1+ exosome release will be increased in humans with or at risk for T1D.
We will quantify differences in total and islet-derived EV PD-L1 in human plasma or pancreas
slice media and compare to nondiabetic controls. Testing will also be performed in plasma from
individuals with longstanding T1D with or without residual detectable C-peptide to determine if
plasma islet-derived EV PD-L1 is linked to functional β cell survival. This work will lead to a
paradigm shift in the field’s understanding of β cell communication with surrounding cells, and
determine the clinical potential of islet-derived PD-L1 exosome cargo as a therapeutic targeting
β cell survival or a biomarker to dissect T1D disease-related heterogeneity.

Public health relevance
PROJECT NARRATIVE Preliminary data have identified the presence of the transmembrane immune checkpoint protein programmed death-ligand 1 (PD-L1) in β cell exosomes, with increased PD-L1 loading in response to inflammatory cytokine treatment of parent β cells. The goals of this project are to: 1) Define molecular signaling pathways regulating β cell PD- L1 exosome cargo under diabetogenic conditions; 2) Determine the functional relevance of specific β cell exosome PD-L1 cargo transfer to surrounding β cells and T cells; and 3) Define relevance of altered exosome PD-L1 cargo to human T1D. This work will address a critical gap in knowledge regarding β cell exosome biology and has the potential to inform novel diagnostic strategies aimed at dissecting heterogeneity in T1D.